A high-speed volumetric multiphoton microscope for the study of developing neural circuits in retina

Our research goal is to determine the factors that instruct the development of visual responses in the mammalian retina. In particular, we are studying the developmental period when the retina transitions from generating retinal waves to mediating visual responses by forming functional circuits. Utilizing a high-speed volumetric two-photon microscope will enable the first description of spontaneous firing patterns across identified microcircuits, such as those that mediate direction selectivity. Our work will determine what role early spontaneous activity plays in wiring up circuits during development.

Public health relevance
A major focus of modern neuroscience is neural circuits—their function, development, role in behavior, and dysfunction in neurological disease. Neural circuit research has been revolutionized by powerful new techniques, including advanced imaging techniques to monitor fluorescent reporter proteins that are genetically expressed in specific neurons, and calcium and voltage imaging methods to assess ensemble activity in circuits. Here we propose to utilize high-speed volumetric two photon imaging during visual stimulation to study the formation of functional neuronal circuits in the developing retina.